RFA-DP-21-001 DP006592 Component A - Michigan Pregnancy Risk Assessment Monitoring System (8.11.20)

MI PRAMS COMPONENT A - PROJECT SUMMARY / ABSTRACT
The Michigan Pregnancy Risk Assessment Monitoring (MI PRAMS) project is an ongoing, annual,
population-based survey of Michigan mothers who had a pregnancy that ended with a live birth. The
goals of MI PRAMS are to ask these mothers about their knowledge, attitudes, and health behaviors
before, during, and after pregnancy. Special attention is devoted to social determinants of health and
health disparities. The project aims are to conduct the survey using sound methodology, provide high
quality population-level data to the survey stakeholders, and help improve the health of Michigan's
mothers and babies.
Mothers are selected for MI PRAMS in a stratified manner from all birth certificates filed during a
calendar year and are contacted by mail and by telephone. MI PRAMS over-samples from mothers
who had a low birth weight infant, from African American mothers, and from mothers in the Southeast
region of the State that contains Detroit and other socioeconomically diverse areas. Our intent with
this sampling strategy is to learn as much as possible from mothers who have already had a
pregnancy that resulted in a poor outcome for the infant (e.g., low birth weight). We also have greater
representation from mothers more likely to have negative complications during and after their
pregnancy, and from those whose infants are more likely to have poor health outcomes.
MI PRAMS data are used by many departments within the State for tracking trends over time,
evaluating the effect of public health interventions, and for allocating resources and attention. The
data will also be utilized by researchers who wish to understand how factors from pregnancy and
infancy affect health throughout the lifespan. In addition to asking about long standing issues such as
pregnancy intention, breastfeeding duration, safe sleep habits, and prenatal care, the next phase of
MI PRAMS will cover emerging topics of public health interest. Mothers will be asked about:
• How the coronavirus pandemic affected their household during pregnancy
• Use of prescription pain relievers and cannabis before, during, and after pregnancy
• The degree of support provided by their partner or spouse
• Adverse experiences from her own childhood
• Plans and intention to vaccinate her new baby
• The quantity and quality of sleep she has at the time of the interview (3-6 postnatal months)
The answers from these and other questions will help MI PRAMS to not only monitor the health of
mothers and babies in the State, but to equip public health professionals with the knowledge to make
positive changes in the health of future generations.

Public health relevance
MI PRAMS COMPONENT A - PROJECT NARRATIVE The Michigan Pregnancy Risk Assessment Monitoring System (MI PRAMS) is an annual survey of the health of mothers and babies within the State of Michigan. The survey is sent out to a portion of women randomly selected from all Michigan residents who have a live birth in the state during a given year and is vital for knowing how common are the factors that can have positive or negative effects on a pregnancy. The end result of MI PRAMS is a collection of annual estimates that represent the health of all mothers and babies in the State; these estimates are useful for planning government spending and tracking the success of programs that improve maternal and child health.